Targeting CNTF to increase adult forebrain neurogenesis

Project Summary. CNTF mediates the increased SVZ neurogenesis that occurs in the mouse brain after
ischemic stroke. We will follow up on our finding that JNK in astrocytes represses CNTF expression and
neurogenesis in naïve mice, to test whether systemic treatment with JNK inhibitor can increase neurogenesis
after stroke. We will also block the highly related pro-inflammatory ligand IL-6, which we found reduces stroke-
induced neurogenesis, with a gp130 inhibitor. Secondly, we have discovered that blood levels of vitronectin
(VTN), produced by the liver, only increase in females after stroke, and leaks into the SVZ to induce IL-6 and
repress the neurogenic response. We will identify the mechanisms that regulate VTN, focusing on vagal nerve
stimulated muscarinic receptors and FAK. Thirdly, we discovered in males that castration caused an
unexpected and very robust effect by increasing basal levels of pro-neurogenic CNTF and decreasing
detrimental IL-6, and that this was retained after MCAO. We will define the differential signaling pathways
underlying this male-specific mechanism and test whether pharmacological blocking of testosterone would
increase neurogenesis in males. Aim 1 will determine whether a gp130 inhibitor promotes neurogenesis when
given at 6 h or 2 months after a stroke in adult and aged mice, and whether it acts by blocking IL-6. We will
also determine whether JNK inhibition would increase neurogenesis after stroke by increasing CNTF, and/or
whether JNK inhibitor would further enhance the neurogenic effects of SC144 after MCAO. Aim 2 will define
potentially female-specific mechanisms that regulate liver VTN, including FAK and muscarinic acetylcholine
receptors, testing pharmacological FAK inhibition and the role of the nervous system innervation of the liver
after MCAO. Aim 3 will define the signaling pathways that mediate testosterone’s effects on CNTF, LIF and IL-
6 expression in the SVZ after MCAO, and using intracerebral injection of testosterone after castration, with or
without FAK, JNK, ERK or p38 inhibitors, and whether a testosterone blocker can promote neurogenesis after
MCAO. These studies will build on our previous work to define novel fundamental intracellular signaling
mechanisms that repress and enhance the key cytokines CNTF and IL-6 involved in SVZ neurogenesis
following stroke.

Public health relevance
Project Narrative This grant examines how we can stimulate the formation of new brain cells after stroke by using pharmacological drugs to increase molecules that promote neurogenesis and block those which reduce it. We will also study how we can block blood vitronectin in females and the male hormone, testosterone, in males, as they seem to play a unique detrimental role in blocking new cell formation. We expect to identify new treatments to maximize new cell formation after stroke, with different treatments for women and men, which might extend beyond to treatments of other neurological disease.